Education and Cognitive Functioning in Later Life: The Nation’s High School Class of 1972

PROJECT SUMMARY/ABSTRACT
Education is among the most important determinants of later-life cognitive functioning and biological markers of
AD/ADRD risk. However, we know very little about how, why, or for whom education matters for these cognitive
outcomes. This makes it difficult to design effective early life preventative interventions. To know how and why
education matters for later-life cognitive functioning and biological markers of AD/ADRD risk, we need high
quality prospective studies that follow diverse young people through schools and across adulthood; that measure
key and modifiable educational contexts, opportunities, and outcomes; that observe midlife socioeconomic
attainments; and that assess cognitive functioning and biological markers of AD/ADRD risk in late life. To date,
no such studies exist.
This project brings together an established and interdisciplinary team of neurologists, neuropsychologists,
sociologists, education scientists, survey methodologists, biostatisticians, and neuroimaging experts who will re-
contact surviving members the National Longitudinal Study of the High School Class of 1972 (NLS-72;
N=14,489). NLS-72 is a nationally representative and highly diverse random sample of Americans first
interviewed as high school seniors in 1972. Following protocols developed and successfully deployed in the High
School and Beyond (HSB) cohort in 2014-2015 and 2021, the team will conduct in-home interviews that include
extensive cognitive assessments and anthropometric measures; in-home visits to gather whole blood; and (for
500 people near one of five regional centers) neuroimaging via harmonized magnetic resonance imaging (MRI).
The resulting data—which will be securely released to the wider scientific community during the project period—
will be used to conduct transformative analyses of the effects of educational contexts, opportunities, and
outcomes on risk of AD/ADRD as observed in cognitive assessments, blood-based markers of neuropathology,
and neuroimaging. The project has four aims: (Aim 1) To estimate the extent to which education shapes
biological, neurocognitive, and behavioral markers of AD/ADRD risk at age 70; (Aim 2) To estimate the extent to
which adult socioeconomic attainments mediate the effects of education on vascular health, pace of biological
aging, and cognitive functioning at age 70; (Aim 3) To estimate the extent to which racial and ethnic differences
in the quality of and returns to education account for disparities in markers of AD/ADRD risk; and (Aim 4) To
securely disseminate newly collected NLS-72 data for wide use by the research community. The analyses made
possible by the newly collected data will transform our understanding of how and why education and other early
life factors impact AD/ADRD risk and resilience.

Public health relevance
PROJECT NARRATIVE This project will transform our understanding of how, why, and for whom education shapes risk of Alzheimer’s Disease and Related Dementias (AD/ADRD). Using new survey, biological, and MRI data collected from a uniquely valuable ongoing cohort study (The National Longitudinal Study of the High School Class of 1972), we will answer questions about (a) how and why education affects AD/ADRD risk; (b) the extent to which adult socioeconomic attainments mediate those effects; and (c) the extent to which racial and ethnic differences in the quality of and returns to education account for disparities in AD/ADRD risk. Our findings—as well as the data that we will disseminate widely—will inform efforts to use educational interventions to reduce AD/ADRD risk and narrow racial and ethnic disparities in cognitive functioning of future cohorts of older Americans.